Development of phospholipid-based nanotherapeutics for treating abdominal aortic aneurysm

PROJECT SUMMARY/ABSTRACT
Abdominal Aortic Aneurysm (AAA) is a life-threatening vascular condition associated with high mortality rates
upwards of 80% upon rupture. Vascular inflammation plays a primary role in AAA, with chronic inflammation and
degradation of the extracellular matrix leading to segmental dilation of the aortic wall. However, clinical trials
involving anti-inflammatory therapeutics have failed to yield meaningful results. Currently, there are no FDA-
approved therapeutics to treat AAA. Our lab has demonstrated that treatment with synthetic high-density
lipoprotein (sHDL) nanoparticles has a protective effect in AAA, leading to a nearly two-fold reduction in AAA
incident and aortic diameter, highlighting the potential of sHDL for AAA treatment. Thus, the objective of this
proposal is to determine the mechanism by which sHDL attenuates AAA pathogenesis and optimize formulation
for effective treatment and delivery. We will accomplish this by 1) developing sHDL particles and determine
underlying protective mechanisms against AAA in vitro. Specifically, the effects of sHDL will be assessed in
vascular smooth muscle cells (VSMC), macrophages, endothelial cells. We will also 2) evaluate and optimize
sHDL treatment in AAA mouse models. The successful completion of this present study will provide robust
mechanistic insight into how sHDL attenuates AAA pathogenesis through its actions at VSMCs, endothelial cells
and macrophages.

Public health relevance
PROJECT NARRATIVE Dysregulated high-density lipoprotein (HDL) levels are strongly correlated with an increased risk of cardiovascular diseases, including Abdominal Aortic Aneurysm (AAA). The use of biomimetic synthetic HDL (sHDL) nanoparticles has been shown to be effective in addressing this risk; however, the mechanism by which sHDL exerts its protective effects in AAA remains unknown. This work aims to describe how AAA pathogenesis is altered by treatment with sHDL, providing critical information for the development of therapeutics aimed at attenuating AAA pathogenesis.